Data Science Core - Center for the Study of Symptom Science, Metabolomics and Multiple Chronic Conditions

ABSTRACT
The Data Science Core of the Center for the Study of Symptom Science, Metabolomics, and Multiple
Chronic Conditions will support the data science needs of the nurse scientist investigators and will
enhance the data science skills of current and future nurse scientists. The Core supports the aims of
the Center by working with the pilot and other nurse scientist investigators as they develop the
research plans for their projects. In particular the core will collaborate on study design and
implementation, as well as data collection, management, analysis, and dissemination. The Core
provides expertise in the analysis of metabolomics and microbiome data, of particular relevance to
the aims of the pilot studies proposed. In addition the core will work with the pilot investigators as they
prepare manuscripts and presentation, providing assistance with interpretation and visualization of
results. With respect to data management, the Core will work with the pilot project investigators to
develop projects within Emory’s REDCap and LabKey systems for managing the clinical,
questionnaire, and biological data. In particular, the Core supports standard templates for the
instruments proposed for symptom assessment (e.g., PROMIS Anxiety scale). Moreover the Core will
implement common data elements for each study. The Core will implement Quality Control and
Quality Assurance procedures for data collection and management. Data will be stored securely in
order to preserve privacy and confidentiality. The Core has implemented reproducible workflows for
metabolomic and microbiome analyses using R, R Markdown, Git, and GitHub, which also assures
version control. The Core will also support resource sharing, uploading data to the Emory Dataverse
as well as creation of an NCBI BioProject.